A new regulator of mucus production integrating temporal and microbial cues

Project summary
The gut microbiome is a dense, complex community of microbes associated with maintaining health in
not only the gastrointestinal tract, but also other organs in the human body. Large shifts that disrupt microbial
homeostasis are linked to digestive diseases, but diurnally rhythmic fluctuations in microbial populations are
associated with good gut health. Therefore, it is of critical importance to delineate the microbial and temporal
cues that control intestinal homeostasis to uncover the mechanisms that separate the beneficial and detrimental
effects of microbial flux. These discoveries have the potential to reveal novel targets urgently needed for treating
colitis, a digestive disease for which a cure remains unknown. We performed a time-course transcriptomics
screen and single-cell transcriptomic analyses from mouse colon and identified a new intestinal gene associated
with the secretory epithelial lineage that exhibited both rhythmic and microbiota-dependent expression. Mice
lacking this protein had a thinner mucus layer compared to wild-type mice, and were not only more susceptible
to DSS colitis, but also displayed delayed recovery after DSS cessation. Our preliminary results implicate host
circadian clock and gut microbiome in this phenotype, but specifics of the upstream temporal and microbial
signals that activate this gene, as well its downstream function in mucus production, remain completely unknown.
Therefore, we hypothesize that the host circadian clock and gut microbiome regulates mucus production in the
large intestine through a newly identified temporal and microbially regulated gene to protect the host from
infectious and chemical colitis. To test this hypothesis, two specific aims are proposed. In Aim 1, we will identify
specific microbiota members and metabolites and investigate circadian clock-dependent regulation that activate
mucus production. In Aim 2, we will characterize the function of our novel protein plays in mucus production by
comparing mucus secretion, permeability, and composition in wild-type and knockout mice. Successful
completion of this proposal will identify a previously undefined mucosal protein that integrates temporal and
microbial cues to regulate mucus production and protects the host against chemical and infectious colitis. This
innovative project will additionally expand my training to include key methods and concepts in microbiota,
chronobiology, and mucosal immunology. Altogether, the research and training plan proposed will facilitate a
better understanding of the role the microbiome and circadian clock in modulating host immunity, while preparing
me for a future career as an independent investigator studying the role the circadian clock and microbiome play
in aggravating digestive diseases.

Public health relevance
Project narrative As incidences of digestive diseases continue to rise, there remains an urgent need to discover new therapeutic targets to alleviate the devastating effects of chronic colitis. Although the intestinal microbial composition is known to modulate gut health, the precise mechanism by which the gut microbiome influences host immunity to exacerbate chronic inflammatory bowel diseases remain largely unknown. In this application, we propose to study how the microbiome and circadian clock cooperate to enhance mucosal immunity and protect the host against colitis, thereby generating candidate targets that may ultimately aid in the design of new therapies.